Identification of brain metabolomic profiles associated with dementia

PROJECT SUMMARY/ ABSTRACT
Identifying mechanistic pathways underlying Alzheimer's Disease/Alzheimer's Disease-Related Dementias
(AD/ADRD) is critical to discovering new targets to test for preventive and therapeutic interventions. Metabolic
dysregulation, both systemic (e.g., diabetes) and cerebral (e.g., dysfunctional lipid/insulin signaling), is
associated with higher dementia risk and AD-related neuropathology. Growing evidence from genetic and
molecular research, and initial studies of metabolomic profiling in postmortem brain tissue, collectively indicate
that metabolic mechanisms may underlie AD/ADRD. However, the specific brain metabolic pathways involved
in AD/ADRD are not well-understood; and critical research gaps remain. First, existing metabolomic studies in
brain tissue – the target organ of dementia – have modest sample sizes and limited replication. Second,
deeper interrogation is needed for brain biochemicals that appear related to brain function (e.g., complex lipids
and fatty acids, lipid mediators of inflammation, gut microbiome-related neurochemicals, glucose/bioenergetic
metabolites). Finally, the plausible causal role of brain metabolic regulation in dementia is yet to be explored.
The overarching goal of this proposal is to comprehensively examine brain metabolites associated
with cognitive decline. Specifically, we will use clinical, neuropathologic, and genomic data, as well as
postmortem brain tissue from 1,200 deceased individuals from two community-based aging cohorts – the
Religious Orders Study (ROS) and Rush Memory and Aging Project (MAP). For the proposed research, we will
leverage existing brain metabolomic data in ROSMAP, and strategically generate new data by extending the
sample size as well as metabolites profiled -- allowing us to examine a total of ~1,800 metabolites across three
platforms. In Aim 1, we will use agnostic discovery to identify and then independently replicate metabolites and
metabolomic coregulatory networks associated with cognitive decline; and we will integrate genetic data using
Mendelian randomization analyses to infer plausible causality. In addition, as a novel approach to discovery, in
Aim 2, we will anchor discovery to a metabolic risk factor for dementia. Specifically, diet is integral to
metabolism, and healthy dietary patterns are associated with slower cognitive decline and lower dementia risk;
thus, we will identify brain metabolomic profiles associated with healthy dietary pattern in MAP, and then test
these profiles in relation to cognitive decline in ROS. We have successfully utilized such approaches in our
prior work. Finally, in the exploratory Aim 3, we will identify metabolomic profiles associated with cognitive
resilience (the ability to maintain cognition despite the presence of neuropathology). IMPACT: Led by an Early-
Stage Investigator and supported by an interdisciplinary team of experienced researchers, this proposal is
poised to discover novel brain metabolic pathways associated with cognitive health, and provide new
evidence that may inform novel interventions. In addition, we will generate extensive brain metabolomics
data to share with the scientific community, yielding a significant and sustained impact on the field.

Public health relevance
PROJECT NARRATIVE Metabolic dysregulation has been implicated in dementia; however, our understanding of metabolic pathways underlying cognitive health is still inadequate. This application aims to systematically investigate brain metabolomic profiles associated with cognitive decline and dementia, by examining approximately 1,800 metabolites in postmortem brain tissue, leveraging data and biospecimens from 1,200 deceased participants in two community-based aging cohorts. Findings from this research may provide critical evidence to fill in the current knowledge gap and to inform the development of novel interventions for the prevention and treatment of dementia.